Administrative Core

PROJECT SUMMARY – Administrative Core
American Indian and Alaska Native (ANAI) communities are increasingly asserting tribal sovereignty over
research, setting their own research agendas, and building capacity to lead and conduct their own
research. Southcentral Foundation (SCF), a tribal health care organization serving 65,000 ANAIs in
Alaska, established a Research Department (RD) in 2006 to conduct health research for and by ANAI
people that aligns with organizational and community priorities and values. Through implementation of
training, grant management software, and expanded program evaluation, prior NARCH funding has
strengthened the SCF RD's ability to administer and evaluate individual research projects within a diverse
and burgeoning research portfolio. This Center will expand this portfolio with a focus on dissemination and
implementation research designed to improve ANAI health outcomes and healthcare delivery.
The overarching goal of the proposed Administrative Core is to position SCF to be competitive for large,
multi-component National Institutes of Health center grants which have been awarded primarily to academic
institutions. We will expand SCF's capacity—and create a new ANAI career pathway—to administer,
communicate, and collaborate across multiple, simultaneous tribal research projects and teams and add
critical capacity to systematically evaluate individual and collective research and capacity-building efforts.
The Specific Aims of this project are to: 1) Implement an ANAI Research Administrator position and
mentoring program to support the administrative, coordination, and communication needs of
complex, multicomponent center grants; and 2): Institute a unified evaluation framework to
assess research outcomes and processes, as well as capacity building efforts in a tribal health
setting. We will develop and implement a curriculum to prepare Research Administrators to lead
Center administrative tasks and ensure the Administrative Core effectively serves as the
communication and coordination hub for study teams and partners and supports evaluation and
oversight functions. We will use two complementary dissemination and implementation research
frameworks (Reach, Effectiveness, Adoption, Implementation, and Maintenance [RE-AIM] and the
Consolidated Framework for Implementation Research [CFIR]) to evaluate individual Center
components and the Center overall to facilitate learning about implementation in tribal health systems.
This effort will be led by Dr. Denise Dillard, an Inupiaq Eskimo psychologist who has served as the Director
of the SCF RD since 2008. Julie Benson, Program Director of the $17.7 million Alaska IDeA Network of
Biomedical Research Excellence, will serve as co-investigator.